A Novel Hybrid Viral Vector for Therapeutic CRISPR Insertion of Multiple Transgenes

PROJECT SUMMARY
Existing delivery systems for CRISPR-Cas gene editing machinery have very little capacity for making multigenic
insertions. As such, the scope of existing gene therapies has been limited primarily to monogenic diseases. Yet
multigenic insertions could facilitate treatment of a much broader range of conditions. To address this challenge,
I am developing a chimeric AdAAV gene editing delivery system by physically linking multiple adeno-associated
viruses (AAVs) to the surface of adenovirus (Ad). I am using the SpyTag-SpyCatcher technology for site-specific
covalent conjugation. In my design, the Ad will encode the Cas9 protein and the gRNAs while the AAVs will
provide a single-stranded DNA template. To enable multigenic genetic insertions, I will conjugate a mixture of
AAVs (with distinct genetic cargos) onto the Ads. Each AAV cargo sequence will undergo programmable
insertion into a unique genomic target site via the Cas9 and gRNAs encoded in the Ad. I anticipate that the strong
and targetable transduction of the Ad will efficiently drive the uptake of AdAAV particles into cells. I also anticipate
that greater in vivo gene editing efficiencies may occur using this design because of the known benefits of single-
stranded DNA templates for homology-directed repair (HDR). My fully novel AdAAV vector will act as an
efficacious and versatile platform for multigenic gene therapy. AdAAVs will be particularly suited for treating
aging and aging-related conditions, especially Alzheimer’s disease.

Public health relevance
PROJECT NARRATIVE This research aims to create an entirely new hybrid viral vector delivery vehicle for CRISPR gene therapy which will be able to efficiently insert multiple genes into specified locations within the genomes of target cells. In the long term, this platform technology will enable genetic treatments for complex ailments of aging and aging-related conditions, especially Alzheimer’s disease.